Transdisciplinary approaches for maternal-child health: a focus on gestational weight gain

PROJECT SUMMARY/ABSTRACT
Gestational weight gain has profound consequences for mothers and their children. However, roughly 70% of
pregnant individuals in the United States do not fall within the recommended range for gestational weight gain.
Despite the significant public health burden of insufficient or excessive gestational weight gain, intervention
strategies have had limited success and are often difficult for individuals to adhere to outside of clinical trials.
Additional opportunities for prevention, early modification, and/or reduction of adverse outcomes may be
gained with a better understanding of the causal pathways leading to and resulting from gestational weight
gain. Novel research approaches, adding biological and clinical perspectives, delving further into upstream
determinants, and dissecting periods of gestational weight gain that affect later outcomes, are necessary to
curb the multigenerational adverse effects of gestational weight gain outside of recommendations.
The research objective of this proposal is to discover novel risk factors and biologic pathways underlying
gestational weight gain as well as outcomes associated with patterns of weight gain during pregnancy; thereby
enabling targeted interventions and further refinement of current guidelines. We will pursue the following
specific aims: 1) apply machine learning models to electronic health records (EHRs) to predict excessive and
inadequate gestational weight gain, 2) examine the causal effect of prepregnancy glucose on gestational
weight gain using Mendelian randomization, and 3) investigate the impact of gestational weight gain
trajectories on risk for adverse pregnancy and maternal outcomes using longitudinal latent profile analysis. To
achieve these aims, we will utilize data from individuals with documented pregnancies in Vanderbilt University
Medical Center’s (VUMC) Synthetic Derivative, a large EHRs database, as well as a DNA DataBank linked to
deidentified EHRs at VUMC (BioVU), and publicly available summary statistics from a genome-wide
association study of gestational weight gain. The proposed research will advance clinical care by identifying
modifiable prepregnancy risk factors, characterizing at-risk individuals prior to pregnancy, and pinpointing
concerning patterns of GWG, resulting in increased opportunities for prevention and intervention.
This research is part of a K01 award for Dr. Elizabeth A. Jasper, Ph.D. Through a comprehensive career
development plan, under the guidance of an exceptional mentor panel, and with access to unique resources,
Dr. Jasper will gain training in biomedical informatics and advanced epidemiologic and statistical
methodologies. Dr. Jasper will acquire the knowledge, skills, and resources necessary to achieve her long-
term career goal of becoming a leading maternal-child health genetic epidemiologist who focuses on identifying
the prepregnancy, prenatal, and perinatal origins of adverse health outcomes.

Public health relevance
PROJECT NARRATIVE Weight gain during pregnancy has profound consequences for mothers and their children. The proposed research will develop prediction models for excessive and inadequate gestational weight gain, identify novel clinical and metabolic risk factors, and determine unique gestational weight gain patterns that are associated with adverse maternal and pregnancy outcomes. The knowledge gained from this study will contribute to a deeper understanding of the mechanisms leading to the variation in gestational weight gain, help to identify high-risk individuals, and pinpoint specific points in pregnancy that contribute to adverse outcomes.